Enhancing the impact of the three CCCEH birth cohorts within the ECHO consortium.

Abstract The Columbia Center for Children’s Environmental Health (CCCEH) has three multi-ethnic birth cohorts contributing to the ECHO Consortium. Children in our cohorts live in the lower income Northern Manhattan and South Bronx neighborhoods of New York City and are comprised of African American and Hispanic women and their children. As described in this supplemental application, we respectfully request additional funding in year 6 to achieve our EWCP milestones and goals. These funds would go principally to increase our staff effort--many of whom are bilingual (English/Spanish) and from the same cultural background, ethnicity, and neighborhoods in which the participants live. The additional funds requested in this supplement will ensure that we can continue to provide extant and newly collected EWCP data from our three cohorts and will create a more equitable situation among all of the ECHO cohorts. With the provision of these additional resources, we will preserve our ability as ECHO members to exert a sustained, powerful influence on the research fields involved and will support the inclusion and representation of diverse participants in ECHO who are traditionally under-represented in research.

Public health relevance
Project Narrative The Columbia Center for Children’s Environmental Health (CCCEH) has three birth cohorts contributing to the ECHO Consortium, comprised of African American and Hispanic women and their children. The goal of this administrative supplement is to adequately support cohort contributions to the ECHO-Wide Cohort Protocol (EWCP) and to ensure that the EWCP includes participants from ethnic and racial populations that are often under-represented in research.